Simulation for Environmental Exposure Education (S3E): A Serious Game Platform for Environmental Health Literacy

ABSTRACT
Simulation for Environmental Exposure Education (S3E)
Studies have documented cumulative health effects of chemical and nonchemical exposures on children that
can impact them for a lifetime. In-home environmental exposure risks are particularly impactful on health
because children spend 80-90% of their time indoors, and impact disproportionately falls on disadvantaged
youth. These environmental exposures have been shown to increase inflammation, asthma, lead poisoning,
cancer and a host of other conditions. In addition, just a subset of these environmentally mediated diseases in
US children is estimated to cost $76.6 billion per year. To provide the knowledge and skills to address these
challenges and to inspire awareness and action, young people need to develop their environmental health
literacy. This project proposes to do that through completing development and evaluation of a mobile serious
game, S3E, to improve environmental health literacy among middle-school age youth by scaffolding learning
and communication about toxic environmental exposures occurring indoors in familiar environments. The game
architecture was built in Phase I using a 2.5D platformer-style architecture with a simulation of socio-physical
dynamics. Players move, interact, communicate, and take action in a virtual experience to avoid environmental
exposure and sickness, injury, or death for others. As the player moves throughout the game, they have access
to data about the environment. The game has embedded real-time displays that inform students of simulated
sensor readings for contaminant levels in air, water, soil, surfaces, and bodies of humans and pets. Increasing
adverse health in response to these contaminants is represented by animated acute symptoms in players and
non-player characters (family, pets, etc.), such as dizziness, nausea, coughing, difficulty breathing, or
unconsciousness. In the process of playing the game, students discover customized solutions to reduce
exposure (opening a window, removing a heater, etc.) and build models and mechanisms of environmental
exposure. The game allows customization of hazards by the teacher to reflect community hazards and
multiplayer options. The content will be aligned with Environmental Health Literacy and Science and Engineering
practice in the Next Generation Science Standards to facilitate integration of the game into formal educational
settings. In this Phase II project we will: develop equations for each environmental hazard to ensure data driven
accurate in-game simulations; complete development of the game in mobile and online formats with all specified
environmental hazard content areas, utilizing youth for iterative feedback and play testing; create a teacher portal
for customization of the game based on teacher/community interests and needs; and conduct a randomized
clinical trial to assess the impact of the game on environmental health literacy and action.

Public health relevance
PUBLIC HEALTH NARRATIVE Exposure to environmental toxins in the home has a detrimental impact on the health of children. Environmental risk includes such things as mold, smoke, lead, radon, carbon monoxide, and many others. These types of environmental exposures have been shown to increase the rate of many health conditions, including inflammation, asthma, lead poisoning, and cancer. The cost of just a subset of environmentally mediated disease in US children is estimated to cost more than $76 billion per year. This research will complete development of an online/mobile serious game that will improve the environmental health literacy of middle school aged youth and test the effectiveness through an evaluation. The game, if effective, will increase their knowledge and understanding of environmental risks and spur them to take action to reduce their risk and the risk to others. This will ultimately reduce the impact of environmental exposure in the home leading to healthier children and a healthier population overall.